Next Generation ALPHA Zebrafish Tank Washer: High Throughput with Reduced Environmental Impact

Zebrafish is a premier research organism for the genetic analysis of vertebrate development and modeling
human birth defects and disease. The Zebrafish Facility at Washington University School of Medicine in St. Louis
is a shared-used facility. This 5,644 sf state-of-the-art facility accommodates a total of nearly 9,000 tanks in four
animal holding rooms with independent recirculating water systems. The Facility provides optimal conditions for
the rearing and maintenance of up to 200,000 fish. Starting with four zebrafish laboratories in 2011, the Facility
currently supports research of 33 independent laboratories. Presently, over 100 graduate and undergraduate
students, postdoctoral fellows and scientists carry out research in the Facility that is supported by R00, R01,
R54, and P01 grants from the National Institutes of Health. The Facility also supports other educational and
outreach programs. The Facility enables these programs by ensuring superior husbandry with automatic feeding
that halves the time zebrafish grow to adulthood; supplying wild-type lines and embryos for experimentation,
cryopreserving sperm to minimize the number of lines maintained as life stocks, conducting pathological testing;
maintaining Quarantine System for imported lines, providing research services such as genome engineering,
and washing and disinfecting holding and breeding tanks and their components to ensure safe and efficient
research operations.
The continued increase of the zebrafish users and expansion to 9,000 tanks requires modern, technologically
advanced equipment to clean and disinfect, on a daily basis, hundreds of holding and breeding tanks, and tank
components as well as fish nets to ensure safe and efficient zebrafish research. Here we propose replacing the
existing 900 GP Walk in Washer (Tecniplast) with the next generation ALPHA Walk in Washer model
(Tecniplast). The existing 900 GP Washer is a prototype aquatics washer with several limitations: it uses steam
lines to heat water, is energetically inefficient, requires long wash cycles, uses an external chemical dosing
system, and breaks down frequently. These inefficiencies and frequent downtimes increase manual labor,
limiting and slowing down the Facility operations and research activities it supports.
The ALPHA model deploys adaptive cleaning technology that combines independent vertical and oscillating
movements allowing for superior water coverage. The ALPHA washer uses electricity to heat water, shorter
wash cycles and thus higher throughput that would meet the continually growing washing needs of the zebrafish
researchers. The reservoir for the chemicals used during wash cycles fit into the machine footprint. Operations
with the ALPHA Washer would reduce environmental impact with a shorter wash cycle and consuming smaller
amounts of chemicals per cycle. The proposed upgrade to the modern ALPHA Walk in Washer would
dramatically improve the washing capacity of zebrafish holding and breeding tanks; would meet the needs of the
growing zebrafish research operations and would also reduce the Facility’s environmental impact.

Public health relevance
The Zebrafish Facility at Washington University School of Medicine in St. Louis is a state-of-the-art shared- used facility, which is supporting research of 33 laboratories and over 100 trainees and scientists. The continued increase of the zebrafish users and expansion to 9,000 tanks requires modern, technologically advanced equipment to clean and disinfect hundreds of holding and breeding tanks on a daily basis. We propose to upgrade the current inefficient washer to the next generation ALPHA Walk in Washer that would dramatically improve the washing capacity to meet the needs of the growing zebrafish research operations while also reducing the Facility’s environmental impact.